NC STATE MOLECULAR BIOTECHNOLOGY TRAINING PROGRAM (MBTP)

Project Summary
Training in molecular biotechnology is essential for an expanding list of disciplines that have found modern
biology‐based skills of critical importance in pursuing research goals in areas ranging from biochemistry to
chemical engineering to plant biology. Recognizing this, NC State University has created a core education facility
that serves campus‐wide needs for graduate students requiring laboratory‐based training in aspects of modern
biology. This not only facilitates completion of the students' dissertation research, but also lays the basis for
career opportunities in academic, government, and industrial research settings. Using this campus educational
resource as a framework, NC State University proposes a Molecular Biotechnology Training Program (MBTP)
to foster graduate-level training in modern biology that will involve students from at least four Colleges and 13
university Departments/Programs. An Executive Committee chaired by the Directors will lead the operation of
the MBTP and oversee sub-committees focusing on program elements. The specific objectives of the training
program are: 1) Ensure technical proficiency and training in responsible and rigorous science; 2) Provide an
educational and professional experience that satisfies graduates' expectations; and 3) Foster robust PhD
graduation outcomes. Ten trainee slots are requested that will be augmented by four slots funded from university
resources. The program requirements include: a graduate-level, laboratory minor in Molecular Biotechnology;
an off‐campus, 3-month industrial internship; a capstone biotechnology design course; a course in professional
development; courses in research ethics; a course in scientific rigor and reproducibility; an annual research
symposium; and a biotechnology ‐ related outreach project. These requirements are in addition to those
associated with the student's particular Department or Program for the doctoral degree. This program will also
provide a central focus for faculty of the various disciplines involved in this training effort to seek out new
opportunities for formal and informal research collaboration.

Public health relevance
Project Narrative Advanced training in molecular biotechnology is critical to modern biomedical science research and should be a key component of pre-doctoral education for students aspiring to academic, industrial, and government research careers. This training should be done in an inclusive environment and complemented by an appreciation of responsible conduct of research and scientific rigor and reproducibility. Furthermore, students should be given opportunities for professional development through a variety of mechanisms, including workshops and internships.